COMBINED ZIDOVUDINE/LAMIVUDINE VS DDI MONOTHERAPY VS ZDV PLUS DDI IN HIV

Purpose of this study is to compare 3TC plus ZDV with the better of ddI monotherapy, and ddI plus ZDV combination therapy in symptomatic HIV-1 infected, antiretroviral therapy naive children.